Estimating Mediation Effects in Prevention Studies

The purpose of this competing continuation grant proposal is to develop, evaluate and apply
methodological and statistical procedures to investigate how prevention programs change outcome
variables. These mediation analyses assess the link between program effects on the constructs targeted
by a prevention program and effects on the outcome. As noted by many researchers and federal
agencies, mediation analyses identify the most effective program components and increase
understanding of the underlying mechanisms leading to changing outcome variables. Information from
mediation analysis can make interventions more powerful, more efficient, and shorter. The P. I. of this
grant received a one-year NIDA small grant and four multi-year grants to develop and evaluate mediation
analysis in prevention research. This work led to many publications and innovations. The proposed
five-year continuation focuses on the further development and refinement of exciting new mediation
analysis statistical developments. Four statistical topics represent next steps in this research and include
analytical and simulation research as well as applications to etiological and prevention data. The work
expands on our development of causal mediation and Bayesian mediation methods that hold great
promise for mediation analysis. In Study 1, practical causal mediation and Bayesian mediation analyses
for research designs are developed and evaluated. This approach will clarify methods and develop
approaches for dealing with violation of testable and untestable assumptions. Study 2 investigates
important measurement issues for the investigation of mediation. This work will focus on methods to
identify critical facets of mediating variables, approaches to understanding whether mediators and
outcomes are redundant, and develop methods for studies with big data. Study 3 continues the
development and evaluation of new longitudinal mediation methods for ecological momentary assessment
data and other studies with massive data collection. These new methods promise to more accurately
model change over time for both individuals and groups of individuals. Study 4 develops methods to
uncover subgroups in mediation analysis including causal mediation methods, multilevel models, and new
approaches based on residuals for identifying individuals for whom mediating processes differ in
effectiveness from other individuals. For each study, we will investigate unique issues with mediation
analysis of prevention data including methods for small N and also massive data collection (big data), the
RcErLitEicVaANl rCoEle(Soeef imnsetruacstiounrse):ment for mediating mechanisms, and the application of the growing literature on
causal methods and Bayesian methods. Study 5 applies new statistical methods to data from several NIH
The project further develops a method, statistical mediation analysis, that extracts more information from
funded prevention studies providing important feedback about the usefulness of the methods. Study 6
research. Mediation analysis explains how and why prevention and treatments are successful. Mediation
disseminates new information about mediation analysis through our website and other media, by
analysis improves prevention and treatment so that their effects are greater and even cost less.
communication with researchers, and publications from the project.